CHARACTERIZATION OF TUMOR ANTIGEN ON LEUKEMIA CELLS

A tumor-associated antigen present on chronic lymphocytic leukemia (CLL) cells has been identified with rabbit xenoantisera prepared against intact CLL cells. The resultant antisera were extensively absorbed with AB erythrocytes, HLA-matched peripheral blood lymphocytes (PBL), and enriched B cells carrying a common alloantigen. Using the [unreadable]51[unreadable]Cr-microcytotoxicity assay and the indirect fluorescent antibody technique, the CLL-associated antigen could not be detected on normal or T or B lymphocytes; cultured lymphoblastoid cell lines; mitogen-stimulated PBL; or thymus, spleen, bone marrow, or lymph node cells. In addition, the tumor antigen was not expressed on malignant cells from other types of leukemia (AML, CML, ALL) but was present on cells from patients with hairy cell leukemia. The tumor antigen was isoIated from CLL plasma membranes by a combination of immunoaffinity and ion-exchange chromatography. Using SDS-PAGE, the tumor antigen was shown to be composed of a single polypeptide with an estimated 69,000 Mr. Recently, we have isolated a retrovirus from cuItured CLL cells and prepared xeno-\and monoclonal antibodies to the virus. Preliminary immunological analysis indicates that antibodies to the virus react with the tumor-antigen and that the antiserum to the tumor-antigen cross-reacts with the retrovirus. Therefore, the tumor-antigen on CLL cells appears to be a component of the CLL retrovirus. (AG)